Differences in Hospital Nursing Resources among Black-Serving Hospitals as a Driver of Patient Outcomes Disparities

Black Americans are more likely to receive care in lower quality hospitals that confer worse health outcomes to
patients. The intractable hospital outcomes disparities have been described for decades and most recently
came to the forefront of public attention with COVID-19 mortality disproportionally affecting Black communities.
Despite multiple studies which attribute a large share of outcome disparities to quality differences in hospitals
where significant proportions of Black patients are treated (i.e., Black-serving hospitals), little is known about
what modifiable factors underlie the poorer quality care. This proposal takes a multilevel perspective to identify
the contributions of individual, social, and hospital determinants to identify modifiable factors that can be
targeted through `upstream' interventions to achieve health equity for Black individuals. We hypothesize that
disparities in hospital outcomes are due, in large part, to inequities in the modifiable nurse resources of
hospitals—with fewer nurse resources in Black-serving hospitals. This uneven distribution of nurse resources
is a vestige of racism that continues to pervade hospital care more than 50 years after the legal desegregation
of hospitals. We focus on nurse resources, since having enough nursing staff to deliver timely and effective
care, a favorable work environment in which nurses have clinical autonomy in their practice and strong
interdisciplinary teamwork, a skill mix rich in registered nurses, and high proportions of bachelors-prepared
nurses and advanced practice nurses, have all been associated with better patient outcomes, particularly for
minority patients. In this study, we evaluate the impact of hospital-level differences in nurse resources on
patient outcomes, including in-hospital and 30-day mortality, readmission, and hospital length of stay. This
observational study of over 900,000 older adult patients in nearly 250 hospitals investigates (1) whether
differences in nurse resources between Black-serving and other hospitals explain outcomes disparities; (2)
whether the outcomes-advantages of having superior hospital nurse resources are enhanced in the presence
of other hospital characteristics, including for example, physician staffing, greater numbers of APRNs, or
teaching hospitals; and (3) estimates the improvements in patient outcomes, such as lives saved, that could be
expected if nurse resources in Black-serving hospitals were similar to other hospitals. Nurse resources are
measured using survey data from over 16,000 nurses in nearly 250 hospitals to describe multiple aspects of
the clinical nurse resources. Using a unique hospital identifier, nurse responses will be linked with Medicare
patient records, demographic and social determinant of health indices. Our analytic approach uses multi-level
nested (hierarchically-related) linear and logistic regression models (with interaction terms) to accomplish our
aims. If our hypotheses are confirmed, the findings will add evidence to inform high-impact actionable
`upstream' solutions to dismantle structural remnants of racism that pervade our healthcare system, by
leveraging the most abundant patient care resource already existing in every hospital—nurses.

Public health relevance
Project Narrative Black Americans have worse hospital outcomes and the hospitals that serve a high proportion of Black Americans are more likely be lower quality; however, little is known about what modifiable aspects of these Black-serving hospitals underlie their poorer quality. In this proposal, we bring a new perspective to the long- standing challenge of achieving health equity in hospital care and patient outcomes, by evaluating whether the differences in hospital nurse resources explain poorer outcomes among those cared for in Black-serving hospitals.